Genetic Factors Mediating Thyroid Hormone-Induced Opsin Switching in Zebrafish Cone Photoreceptors

Specific vertebrate cone opsins with distinct peak spectral sensitivities are expressed in
separate cone populations, which provide differential input to downstream neurons. This
information is interpreted as color. In humans, the opsins that sense red and green light
(LWS/MWS) are encoded by an array of tandemly replicated genes sharing a single locus
control region (L/M array). Defects in this array result in color blindness and more severe cone
degenerative disorders. Zebrafish possess an orthologous tandemly replicated long wavelength-
sensitive array (lws array, red-sensing). The process by which tandemly replicated opsins are
differentially regulated is poorly understood, and filling this knowledge gap would allow the
vision science community to develop treatments for disorders related to defects in the L/M array,
as well as establish conditions for differentiating human cones in vitro for cell replacement
therapies that permit high acuity color vision. The prevalent model for control of the human array
predicts stochastic regulation. However, the presence of topographic gradients in LWS:MWS
cone ratios in human retinas (and LWS1:LWS2 ratios in zebrafish) suggests that a trans
regulatory mechanism is involved. The Stenkamp lab demonstrated that thyroid hormone (TH)
regulates opsin expression in LWS cones, supporting the presence of a trans regulatory
mechanism. The proposed research aims to characterize TH-mediated biological differences
between the LWS cones and to investigate the genetic mechanisms underlying the switch in
LWS cone opsin expression upon TH exposure in zebrafish. We will use single-cell RNA
sequencing (scRNA-Seq) to obtain comprehensive transcriptional signatures of LWS cones
from control and TH-treated zebrafish. We will also use previously collected bulk RNA-Seq and
single-cell RNA-Seq (scRNA-Seq) data to identify genes that are differentially expressed (DE) in
LWS1 vs LWS2 cones, and, after validation, we will determine whether the candidate genes are
coordinately regulated by TH. Thirdly, we will use CRISPR/Cas9-mediated cell type-selective
gene disruption strategies to elucidate the roles of TH receptors (TRs) and retinoid X receptors
(RXRs) in TH-induced opsin switching. This project will provide insight into zebrafish LWS cone
differentiation and ultimately into the mechanisms by which cones expressing one member of a
tandemly duplicated opsin gene array differentiate in general.

Public health relevance
Public Health Impact Statement This project will discover mechanisms regulating the expression of “tandemly-replicated” visual pigment genes, similar to those on the human X chromosome encoding the red- and green-sensitive visual pigments. The results of the proposed studies will provide key information regarding mechanisms through which specific cone photoreceptor types are determined. Manipulation of these mechanisms will be important as the Vision Science community develops regenerative medicine-based methods for replacing photoreceptors that are lost to disease or injury.